Endothelial cell exosomes and fibroblast function

PROJECT SUMMARY/ABSTRACT
This application proposes a customized research training plan designed to promote the development of the
applicant into an independent investigator. The plan includes advanced training in laboratory experimentation,
along with tailored professional and career development opportunities. The training plan is supported by the
outstanding availability of local and institutional resources at UIC. The proposed research will examine cellular
communication mechanisms that control scar formation, a common result of the healing response. In most
tissues, the end result of tissue repair is a fibrous scar containing altered amounts and structure of the
extracellular matrix components. Scarring and fibrosis occurs in numerous tissues and can create serious
functional problems such as limited mobility, restricted skeletal growth, and weakened tissue strength that may
lead to wound dehiscence. In the craniofacial region, scarring can impair both functionality as well as
appearance, leading to a variety of physiologic and psychologic problems. Robust angiogenesis, a prominent
feature of wound repair, includes the creation and then pruning of vessels. Angiogenesis is associated with
increased fibrosis in numerous tissues including skin, lung, and liver. The goal of the proposed studies is to
examine how the endothelial cells that arise during wound angiogenesis communicate with surrounding
fibroblasts and how they influence their function and subsequent collagen deposition. One way that endothelial
cells might communicate with fibroblasts is via small extracellular vesicles, called exosomes. The research
plan utilizes traditional wound healing assays, methods for exosome purification and application, and small
RNA and RNA sequencing tools to study exosome-mediated communication between these two cell types and
to identify the resultant phenotypic changes in fibroblast activity. The central hypothesis of this research is that
exosomes secreted from endothelial cells influence the phenotype of fibroblasts during wound healing and
fibrosis. Our long-term goal is to understand how communication between endothelial cells and fibroblasts
affects the scarring phenotype. Aim 1 will examine the effects of endothelial cell exosomes on fibroblast activity
and fibrosis in vitro and in vivo. In vitro wound healing assays will be employed, and fibroblasts exposed to
endothelial cell exosomes will be assessed for changes in migration, cell cycle phase, proliferation, and gene
expression. An in vivo mouse model will be used to assess fibrosis and collagen architecture after intradermal
injection on endothelial cell exosomes. Aim 2 will utilize bioinformatics tools to identify and characterize the
specific miRNA cargo of endothelial cell exosomes that is mostly likely to impact fibroblast function at sites of
scarring and fibrosis. Together, the Aims will lead to a better understanding of the mechanisms by which
endothelial cells might modulate fibroblast function, and may lead to the development of novel therapeutics to
treat fibrotic diseases.

Public health relevance
PROJECT NARRATIVE Fibrosis is a serious medical concern affecting numerous tissues including skin, lung, and liver. This proposal will study how the blood vessels that are formed during wound healing might influence fibroblasts thus stimulating the fibrotic response. The proposed studies will lead to better understanding of the mechanisms by which exosome mediated communication might modulate fibroblast function and may suggest the development of novel therapeutics to treat fibrotic diseases.